Role of branched-chain fatty acids in physiology and virulence of Staphylococcus aureus

7. Project Summary/Abstract
While some bacterial infections are caused by a single species, we now know that most infections are
polymicrobial in origin. We know that the activities of these species are often synergistic, as interactions between
species enhances virulence, persistence, and tolerance to antibiotics. The end result is patient outcomes are
typically worse in co-infection compared to mono-infection. Staphylococcus aureus is the leading cause of skin
and soft tissue infections. The bacterium is also the most common organism isolated from chronic wounds and
is frequently found with the opportunistic pathogens Enterococcus faecalis and Pseudomonas aeruginosa.
Interactions between S. aureus and E. faecalis are relatively understudied. More broadly, our knowledge of the
molecular mechanisms governing these interactions in chronic wounds is incomplete. S. aureus relies heavily
on the de novo synthesis of branched-chain fatty acids for membrane biogenesis that cannot be obtained from
the host during infection. These membrane fatty acids are essential for avoiding phase separation, protein
aggregation, and cell death. They are also required to promote the activity of the Sae two-component system, a
major regulator of S. aureus virulence. The PI’s laboratory recently discovered evidence for a new pathway
specific to human-associated staphylococci for salvaging and synthesizing branched-chain fatty acids from the
metabolic byproducts of co-infecting bacteria found in chronic wounds. The overall goals of this application are
to i) determine the steps of this novel pathway and how Enterococcus faecalis helps S. aureus construct its
membrane using this pathway during infection, and ii) determine how branched-chain fatty acids promote
signaling via the Sae two-component system to increase pathogenicity. To accomplish these goals we will use
penetrating genetic, biochemical, molecular biological and global approaches to interrogate the functionality of
the proteins we are interested in. In addition we will use cutting-edge native mass spectrometry and spatial
lipidomics approaches along with in vitro and in vivo murine models to define mechanisms. Detailed
understanding of these processes is the important first step toward developing novel therapeutics to combat
these complex infections.

Public health relevance
8. Project Narrative Most bacterial infections are caused by multiple species that collaborate to worsen disease outcomes. The goals of this application are to gain insight into the mechanisms by which the common wound pathogen Staphylococcus aureus i) salvages and synthesizes branched-chain fatty acids in polymicrobial wounds to construct their membrane, and ii) uses these fatty acids to trigger the production of disease-causing factors. The ultimate goal of this research is to develop novel therapeutic strategies for treating polymicrobial infections.